Intelligent and Personalized Online Adaptive Proton Therapy

Project Summary/Abstract
The Bragg peak serves as the foundation for proton radiotherapy (RT), providing particular benefit to reduce
treatment toxicity and improve quality of life for patients with cancers that are very close to multiple critical organs,
particularly for pediatric patients. However, anatomical changes often occur during RT treatment course, caused
by tumor shrinkage, patient weight loss, and daily treatment setup variations. Proton RT is very sensitive to
anatomical changes, as a small density change along the beam path can shift the Bragg peak, resulting in
significant underdosing of tumors and overdosing of adjacent critical organs. Adaptive proton RT (APT) offers a
general solution to account for anatomical changes. However, current APT workflow is resource-intensive in
terms of time and equipment and requires extensive work from the entire clinical team. It typically takes a few
days from the CT image acquisition of patient’s new anatomy to the time when the new plan is ready for treatment,
resulting in 1) interruptions of the treatment course, which can impair the local control and overall survival rate
due to tumor cell repopulation, particularly for cancers of fast tumor repopulation; 2) time delays between the
image acquisition of new anatomy and the treatment delivery of the new treatment plan, which can compromise
the plan’s efficacy due to the continual anatomical changes occurring during the gap. Online APT is much needed
to guarantee high treatment quality throughout the treatment course. While several commercial systems support
online adaptation for photon RT, there is no such system available for proton RT. This gap exists because online
APT requires superior contouring accuracy and more robust online adaptation algorithms that can account for
large anatomical changes due to the Bragg peak's sharp dose fall-off and its acute sensitivity to anatomical
changes. To fill this gap, we propose to develop an artificial intelligence-driven system for online adaptive and
personalized proton therapy (AID-ON-APPT). We envision that this system will calculate the actual daily dose
distribution of the treatment plan based on patient’s daily anatomy and treatment setup, quantify the actual plan
quality before the delivery of each treatment fraction and, if needed, generate a new optimal plan within minutes.
The proposed system will be developed via three specific aims, using head-and-neck cancer as a test bed: 1)
Build two patient-specific deep-learning (DL) models for automatic online delineation of tumor and organs at risk
(OAR) on daily cone-beam CT images; 2) Build a patient-specific virtual replanner network using deep
reinforcement learning and prior knowledge for automatic online replanning; 3) Conduct a clinical study of virtual
online APT on 100 HN patients to test system performance and its potential clinical benefits. Upon successful
completion, the proposed platform will enable online adaptive and personalized proton therapy, which is
expected to improve tumor dose coverage while reducing the dose to critical organs and lead to better local
control, reduced complications, and improved quality of life. This platform will revolutionize current clinical
practices of proton RT, substantially improving clinical efficiency and reducing the needed human interventions.

Public health relevance
Narrative Proton radiotherapy is very sensitive to daily treatment setup variations and patients’ anatomical change during the treatment course. Our proposed study aims to develop an artificial-intelligent-driven online adaptive and personalized proton therapy system, which can calculate the discrepancy between the planned radiation dose and the actual dose distribution in patient’s daily anatomy before the delivery of each treatment and, if needed, generate a new plan for treatment within a few minutes. The proposed system is expected to change current clinical practice and result in a new paradigm of proton radiotherapy, ensuring that the therapeutic dose is delivered to the tumor region as desired at each treatment while minimizing treatment toxicity to improve patients’ quality of life.